Mentoring Patient Oriented Research in the Microbiome of Cancer and Stem Cell Transplant Patients

Project Summary
Dr. Andrew Y. Koh is an Associate Professor in the Department of Pediatrics (Division of Hematology/Oncology)
and Microbiology at the University of Texas Southwestern Medical Center and Director of Pediatric
Hematopoietic Stem Cell Transplantation at Children’s Medical Center Dallas. Clinically trained in both Infectious
Diseases and Hematology/Oncology and scientifically trained in microbiology and immunology. Dr. Koh has
established a successful and independent research program focused on understanding how the gut microbiome
modulates host immune responses in cancer and stem cell transplant (SCT) patients. His experiences as an
active clinical oncologist and infectious diseases specialist, a basic/translational researcher, and mentor have
positioned him to be an ideal candidate for the K24 Mentoring Career Development Award. For this project, he
is particularly interested in using “reverse translational” approaches to identify unique gut microbiome signatures
associated with a particular disease phenotype in patients and then confirming causality in the laboratory using
preclinical and in vitro models. Hence, his research program is well-poised to further dissect and elucidate the
mechanisms by which specific gut microbiota modulate disease phenotypes in cancer and SCT patients with the
ultimate goal of devising novel therapies to modulate the gut microbiota and promote patient health. This work
has been supported by funding from the NIH/NIAID (K08 and R01), the Centers for Disease Control and
Prevention, private foundations, and industry. He has also developed a significant professional interest in
mentoring trainees in translational microbiome research and career development. The K24 award will support
Dr. Koh’s scientific career activities by allowing him to engage in professional development via
coursework/training and execution of novel projects that will enhance his research program and support future
independent funding. In addition to supporting scientific career activities, the K24 award will directly allow Dr.
Koh to pursue mentorship/leadership training and enhance his ability to more deeply engage with specific
mentees pursuing K and R01 awards and more broadly engage with all mentees in patient-oriented microbiome
research. The overall scientific aims of this proposal are 1) To mentor trainees to become patient-oriented
research investigators; 2) To continue and enhance my career development as a leader in translational patient-
oriented research; and 3) To conduct independent translational microbiome research to improve the health of
cancer and SCT patients with a focus on the following specific research projects: a) Mechanisms of gut
colonization resistance to bacterial and fungal pathogens, with a translational focus on devising novel methods
to precisely edit the microbiome and prevent invasive bacterial/fungal infections; b) Gut microbiota-dependent
modulation of graft-versus-host disease; c) Mechanisms by which gut microbiota augment host anti-tumor
response in the context of cancer immunotherapy; and d) Host and microbial determinants of microbial antibiotic
resistance.

Public health relevance
Project Narrative The gut microbiome plays a critical role in shaping host innate and adaptive immune responses. We are investigating how the gut microbiome modulates the immune system in cancer and stem cell transplant patients. This project will train junior investigators on using patient-oriented research to improve the health of cancer and stem cell transplant patients.